Patricia Levy Zusman International Workshop on Neuroregeneration (Zusman Workshop)

Project Summary/Abstract
This R13 originated through discussions with investigators in the fields of neurostimulation and neuroplasticity
at the Houston Methodist Research Institute (HMRI). In 2017, we held an R13-funded pilot workshop that
combined research in neural stimulation with new insight into the molecular understanding of neural plasticity
and regeneration. The workshop received a strong, positive response by participants and interest in further
catalysts of working collaboration. Thus, in 2019, we fostered relationship development and crossover
opportunities among attendees via a blitz session wherein newly formed (i.e., established at the 2019 Workshop)
collaborative teams competed for two $5K mini grants that supported travel to and from each other’s institutions.
In 2021, our R13-funded workshop went 100% virtual due to COVID-19; however, this did not diminish the
Workshop’s impact. With over eighty attendees, many new collaborations were forged, and projects conceived.
Given the overwhelmingly positive feedback, we will host the 4th Patricia Levy Zusman International Workshop
on Neuroregeneration (Zusman Workshop) on March 7th-10th, 2023. It will focus on the intersection of electrical
activity, brain connectomics and molecular neural plasticity. Our specific aims are to: 1) formulate new ideas to
fill the gap between physiology and functional-based brain stimulation technologies and the molecular and
cellular understanding of innate neuronal plasticity; 2) integrate promising trainees into plenary sessions; and 3)
ensure trainees participate in substantial discussions and interactions with faculty members. The 2023 Workshop
will be held at HMRI, which is part of the Texas Medical Center (TMC; a one-of-a-kind medical and research hub
that fosters cross-institutional collaboration, creativity, and innovation) and is in Houston Texas (one of the United
States’ most diverse cities). A key aspect of the Zusman Workshop is the active inclusion and participation of
trainees, particularly women and under-represented minorities. We will encourage their participation via travel
scholarships and active promotion and recruitment throughout the TMC. Also, the Workshop seeks to promote
the voices of graduate and postdoctoral trainees. As such, it will include a trainee poster session as well as a
session dedicated to trainee oral presentations (given by travel awardees). Further, goal-oriented breakout
sessions, led by senior/early-stage investigators and selected trainees, will foster discussion and promote cross-
training and collaboration among participants. Overall, this workshop is distinct from established physiology
conferences and dedicated neural regeneration conferences in several ways. It is: 1) highly focused on the gap
between molecular regeneration and electrophysiology/stimulation, 2) concept driven by clinicians and
experimentalists currently problem solving in human therapy, and 3) focused on the establishment of cross
training and expertise development in graduate, post-graduate, and clinical fellows. The 2023 Zusman Workshop
will ignite innovative collaborations and spur novel multidisciplinary teams to develop innovative, transdisciplinary
methods, technologies, and treatments to modulate performance in the damaged nervous system.

Public health relevance
Project Narrative A large gap exists between researchers who seek to develop methods of neural plasticity and long-distance regeneration and experts who study the outcomes and safety of brain computer interfaces. Therefore, in 2017, we developed and held the first biennial Patricia Levy Zusman International Workshop on Neuroregeneration, which focused on the intersection of electrical activity, brain connectomics, and molecular neural plasticity. In 2023, our goals are to 1) build upon the success of our previous three workshops by inviting back and sponsoring travel for rising star alumni to return and participate; 2) create an interdisciplinary discussion of the gap in these disciplines, and 3) stimulate working groups, training opportunities, and translational approaches to speed progress in directed, stimulation-based regenerative therapies.